A Biomechanocompatible Small Molecule Releasing Scaffold for Bladder Augmentation

PROJECT SUMMARY/ABSTRACT
Patients with a pathologic bladder have chronic medical problems with urinary incontinence, infections, and
potential renal failure. Conventional surgical management of the end-stage pathologic bladder uses
detubularized bowel as a patch (enterocystoplasty) to enlarge the bladder to limit increases in intravesical
pressure. Although enterocystoplasty provides functional improvement, it is associated with significant short-
and long-term complications. Thus, alternative methods to enterocystoplasty have been explored through
tissue engineering approaches. One approach utilized seeding autologous, patient-cultured bladder cells on
synthetic scaffolds as an augmentation patch. With these techniques, poor to marginal results were described
but regeneration of fully functional normal bladder tissue was not achieved. Several obstacles currently limit
the advancement in this research field including: 1) a cell-free approach to drive native bladder tissue
regeneration without the use of suspect, exogenous cells; 2) the lack of a truly translational bladder tissue
regeneration animal model; 3) poor graft peripheral nerve regeneration and vascularization; and 4) primitive
bioscaffold design. Thus, an alternative to these barriers are desperately needed to address unmet clinical
needs. Bone marrow stem/progenitor cells (BMSPCs) represent a highly-defined population of cells and our
group has shown its effectiveness in regenerating bladder tissue. However, there are numerous obstacles that
effect the utility of these cells. These include the quality, low frequency and heterogeneity of stem cells found in
the bone marrow especially in patients with increasing age and those likely to be suffering from bladder
disease. As an alternative, we propose the use of a small molecule that can drive bladder tissue regeneration
in vivo and can either perform similarly to or out-perform analogous BMSPC cell-seeded grafts. This would
eliminate the need of exogenous cell sources for bladder tissue regeneration or bowel for bladder
augmentation enterocystoplasty, where applicable. We have demonstrated that our team can reproducibly
synthesize elastomeric scaffolds that possess anti-inflammatory properties and can mimic the mechanical
properties of the bladder. Lastly, we have established a unique nonhuman primate animal model that is
phylogenetically similar to humans with regards to bladder anatomy and physiology. This proposal will
demonstrate that our small molecule directed platform will promote bladder tissue regeneration that is
anatomically correct and physiologically functional.

Public health relevance
PROJECT NARRATIVE In patients that have abnormal urinary bladders caused by birth defects, trauma, or disease, novel regenerative engineering techniques that are successful in creating new bladder tissue for replacement therapy will be invaluable. Current strategies to regenerate bladder tissue have failed and are hampered by several problems including inadequate development of new blood vessels to the regenerated tissue, tissue innervation, poor bioscaffold design, and animal models that lack significant anatomical and physiological similarities to their human counterparts. This proposal seeks to take advantage of a cell-free bladder tissue regeneration approach, elastomer chemistry, and the implementation of a non-human primate model of urinary bladder tissue regeneration to address these problems in order to improve upon current tissue engineering techniques to make successful regeneration of bladder tissue a reality.